MADIVA (Multimorbidity in Africa: Digital innovation, visualisation and application)

MADIVA is exploring use of data science methods to deal with multimorbidity in
Africa. A key translational aspect of our work is building and evaluating dashboards
that can be used by district health officials such as nurses and clinic managers to
track what is happening in their clinic/district. Most of these individuals are not
trained in data science and visualization. The effectiveness of our intervention will
depend on their willingness and ability to use and interpret the results that we
produce.
The administrative supplement will allow us to (a) evaluate levels of visual literacy
among the target stakeholders; and (b) explore the best ways of improving data
literacy and visualization literacy in stakeholder populations.
Practical steps will include (i) pre-and post- assessment of literacy; (ii) development
of data visualization training material for stakeholders; and (iii) delivery of the
course material once each in South Africa and Kenya. Material will include key data
science concepts as well as various graphing and visualization techniques. This
activity will also help build relationships with key stakeholders and comes in a
response to a direct request from them. All material will be made FAIR, and we
intend to publish the results of the engagements for the benefit of the broader
scientific community.

Public health relevance
The use of dashboards by district health officials to understand and visualize complex health data is a key outcome of MADIVA; the effectiveness of these dashboards depends on data visualization literacy. We will assess levels of data literacy among key stakeholders and develop interventions to improve the ability of nurses and district health officials in African countries to use data science methods, and in particular to use our dashboards.